A remotely - applied behaviorally- designed intervention incorporating gamification, social incentives, and health coaching to improve durability of physical therapy for knee osteoarthritis (ReAKTIV)

Knee osteoarthritis (KOA) is a high-priority problem among the aging population, and in particular, among
veterans. Notably, few interventions have been shown to be effective in the long-term management of
symptoms of the disease. Physical therapy (PT) interventions have been shown to be a safe and effective
strategy to improve symptoms of KOA through strengthening of peri-articular tissues and improving
biomechanics. Current guidelines also support the promotion of greater overall physical activity in order to
address persistent symptoms of OA (e.g., pain, physical function). Recent studies have articulated both the
quality and quantity of physical activity necessary to reduce the symptomatic burden of hip and knee
osteoarthritis. Current organizational guidelines for the non-operative management of KOA also include strong
recommendations for supervised exercise delivered through standard PT and the promotion of greater physical
activity in management plans. While PT is often an effective and safe therapy, longer-term adherence to home
exercise programs and increases in physical activity is low, and benefits of exercise programs are therefore
often short-lived. We have experience using remotely-applied programs to promote healthy behaviors. The
proposed study aims to promote greater adherence to home exercise programs and promote greater overall
physical activity with the long-term goal of achieving maintenance of symptomatic gains for patients that
complete standard PT interventions. We designed both a remote behavioral intervention and health coaching
program to address multiple themes that are known to drive maintenance of behavior change over the long-
term. Specifically, we propose to fill important knowledge gaps in this area with a large, pragmatic clinical trial.
In this study, we will randomize participants in a factorial design to receive the behaviorally-designed remote
intervention, a virtual health coach, or both, after being released from a standard PT intervention with proven
efficacy in order to promote adherence to a home exercise program and greater overall physical activity with
the goal of maintaining the symptomatic gains observed during PT over 18 months. To accomplish these aims,
we will utilize innovative mobile applications for smart phones and wearable activity trackers through the Way-
to-HealthTM platform and assess, in real time, the impact of the intervention on patient-reported function and
pain as well as physical activity levels and adherence to specific knee-related exercises at home. The
technology will allow for the recording of outcomes in real time, as they occur, thereby avoiding information
bias due to poor recall as well as participation bias. The study will follow 240 patients, enrolled over 5 VA sites,
for 18 months during the interventional phase and then monitor them for another 6 months after the
interventions have been removed. The investigative team includes investigators with experience conducting
similar trials using this infrastructure as well team members to inform trial design and support the health coach.
The study involves a centralized organizational structure in close collaboration with investigators across the
country, enhancing the generalizability and feasibility of recruitment. The proposed aims represent a direct
response to a special emphasis area in VA Rehabilitation Research and are informed by a report from the
Evidence Synthesis Program. The successful completion of these aims would support the development and
dissemination of a tool applied remotely and at low cost to add to effective PT interventions that are already
being utilized.

Public health relevance
Exercise therapy is an effective modality for improving symptoms among patients with knee osteoarthritis (KOA), however, the improvements observed are often short-lived due to poor long-term adherence to recommendations provided by physical therapists after discharge. We propose to address this important problem with a practical clinical trial of 240 patients using resources available through the Penn Center for Health Innovation and an innovative factorially-designed study. This multi-site randomized trial will evaluate the benefit of remote health coaching as well as the application of an evidence-based remote behavioral intervention to improve the long-term uptake of behavioral changes necessary to promote long-term durability of symptomatic improvements observed during physical therapy.